OPC-14117 IN PATIENTS WITH HUNTINGTON'S DISEASE

This is a one-year, investigator-initiated, phase II study in 16 patients with Huntington's disease. The protocol is designed to test the safety, tolerance, bioavailability, and efficacy of OPC-14117, a new oxygen free radical scavenger with excellent central nervous system penetration. It will also evaluate the potential benefits of this drug on the movement disorders and mental features of the disease. This study is part of a multi-center trial initiated by the Huntington Study Group, a consortium of clinical investigators and basic scientists with the aim of developing therapeutic agents for HD. The study has been completed and the results have been submitted for publication.